Optimizing semantic memory measures of Alzheimer's disease biomarkers

Recent evidence suggests that neuropsychological testing is sensitive to the accumulation of key Alzheimer’s
disease (AD) pathologies in older adults without dementia. Semantic memory, meaning factual knowledge
about the world, has emerged as a potentially sensitive cognitive domain to early AD pathology. Yet, barriers
limit our understanding of semantic memory’s promise for detecting AD-related cognitive decline. Notably,
efforts to examine semantic memory’s sensitivity to amyloid and tau have not capitalized on key cognitive
mechanisms - identified through advancements in cognitive neuroscience - that may maximize sensitivity to AD
pathology. Additionally, there remains uncertainty as to how semantic memory maps to hippocampal/medial
temporal lobe (MTL) integrity, despite being relevant to revealing mechanisms and profiling AD pathology.
Guided by contemporary cognitive neuroscience theories, the present proposal aims to ascertain, among older
adults without dementia, the sensitivity of several new semantic memory tasks to: 1) a promising plasma
biomarker of AD-specific amyloid/tau pathology and 2) hippocampal/medial temporal lobe atrophy. Led by PI
Dr. Grilli, our team combines expertise in the cognitive neuroscience of semantic memory, hippocampal/medial
temporal lobe functioning, and the neuropsychological detection of early AD. Together, we will undertake an
innovative project integrating novel cognitive assessment, comprehensive neuropsychological profiling,
structural MRI, and plasma assays. We will test, among 225 older adults spanning from cognitively unimpaired
to those with mild cognitive impairment, the relationships between AD biomarkers and several mechanisms of
semantic memory functioning. In Aim 1, we will investigate whether adding precision to semantic memory
enhances this cognitive construct’s sensitivity to AD biomarkers, as measured by plasma and
hippocampal/medial temporal lobe atrophy. Aim 2 will explore our hypothesis that experience-nearness,
another property of semantic memory, is sensitive to the same AD biomarkers. Finally, Aim 3 will assess our
hypothesis that generative processing, as a third semantic memory property, can detect early signs of AD
through our target biomarkers. All three aims are not only informed by contemporary theory but also supported
by extensive preliminary data from our team. The aims also are aligned with the NIH’s Notice of Special
Interest: Novel Approaches to Diagnosing and Studying Clinical Alzheimer's Disease and Related Dementias
(NOT-AG-21-036). This project, to our knowledge, will be the first to evaluate the sensitivity of these three
semantic memory properties to critical, early AD biomarkers. Ultimately, the results of this project may lead to
the development of more sensitive and specific cognitive tools for early tracking of AD-related pathologies, with
broad implications for scientists conducting clinical trials, as well as clinicians on the frontline of healthcare
treatment. The knowledge gained also may significantly advance our understanding of hippocampal/medial
temporal lobe functioning by clarifying the mechanistic role of these neural structures in semantic memory.

Public health relevance
The proposed research is relevant to public health because Alzheimer’s disease is the seventh leading cause of death for Americans, and improved detection of early cognitive warning signs of Alzheimer’s disease is essential for proactive and effective treatment of this disease. This research aligns with the National Institute on Aging’s 21st Century strategic direction to “better understand the biology of aging and its impact on the prevention, progression, and prognosis of disease and disability.” By focusing on semantic memory, the proposed research is uniquely suited to improve detection of Alzheimer’s disease, reveal new cognitive endpoints for therapies, and ensure that clinical care is grounded in contemporary cognitive neuroscience.